COVID-19: SARS-CoV-2 Neutralizing Agents

COVID-19 super pandemic is still suffering from the lack of a vaccine or infection control measures
and the lack of any treatments against this new virus. One of the unique features of SARS-CoV-2 is
that it has an R0=2.2 (the ability of an infected patient to spread the disease) vs R0=1 for SARS-CoV
and R0=0.3 for Influenza. Due to this, individuals infected with SARS-CoV-2 remain asymptomatic
and yet pass on the virus to family, friends and colleagues at work, thus expanding the COVID-19
cases. Given the impending second wave of the pandemic and the potential of SARS-CoV-2 being
a seasonal virus, there is a dire urgent need to develop prophylactic vaccines and/or therapy (PV/T),
which can treat the viral infection during the virus expansion in the lung and during oxygen therapy.
This proposal addresses the COVID-19 pandemic by developing a PV/T, which will be a unique
approach that has not been tested before. This project is inspired by discovery of a special agent,
i.e., a nanoscale 10 kDa chitosan, derived using proprietary methods from chitosan used as a
common diet supplement [‘generally regarded as safe’ (GRAS) by FDA]
, referred to as nanoscale
chitosan derivative (NCD). NCD1 and other chemical derivatives were synthesized and tested for
their anti-viral activity by neutralizing RNA of viruses, such as HIV, respiratory syncytial virus (RSV)
and Coxsackie virus. Thus, in preliminary studies, 5 out of 9 examined showed significant anti-viral
(80-90%) effects. Further, molecular docking studies showed that NCD1 can dock to the Spike
protein of SARS-CoV-2 virus. Finally, we have developed lung targeted nanomedicine methods to
combine NCD1 with remdesivir for improving treatment efficacy and expanding its use for prevention.
Based on data at hand, it is hypothesized that NCDs by themselves or in combination with remdesivir
will provide an excellent PV/T against COVID-19. To test this hypothesis, it is planned to examine in
both prophylactic and therapeutic settings: the antiviral effectiveness of NCDs in vitro lung epithelial
cell cultures (aim #1), the effectiveness of select top two NCDs with or without remdesivir in
EpiAlveolar 3D co-culture model (MatTek) of the air-blood barrier (aim #2), and efficacy of select
NCD with or without remdesivir in in vivo mouse models (aim #3).
The results will provide us in
identifying one or two NCDs as a single agent or in combination with remdesivir as COVID-19 PV/T
regimen(s), which will inhibit SARS-CoV-2 infection. The results of these studies will uniquely
contribute to the repertoire of COVID-19 prophylactics and therapeutics and allow us to move
towards regulatory approval and future clinical trials. The team is uniquely poised to conduct these
studies and has appropriate expertise. The successful completion of the proposed research is
expected to lead to obtaining regulatory approval for a clinical trial.

Public health relevance
Given the impending second wave of the COVID-19 super pandemic and the potential of new SARS- CoV-2 being a permanent seasonal virus, there is a dire urgent need to develop prophylactic vaccines and/or therapy, which can treat the viral infection prophylactically during asymptomatic the virus expansion in the lung and during oxygen therapy. To this end, this proposal aims to characterize novel virus-neutralizing particles that may serve as prophylaxis and/or therapy. In this proposal, these particles will be investigated for their potential and be validated in relevant human cellular and mouse models.